Postdoctoral Training in Translational Neurorehabilitation Research

Abstract
Advances in basic sciences related to cognition, motor control, and neuroplasticity offer exciting
opportunities for treatment advances in neurorehabilitation. Maturation of promising discoveries to
validated treatments faces the translational research challenges familiar to all biomedical domains, while
also encountering some rehabilitation-specific obstacles. Research collaborators from Moss Rehabilitation
Research Institute and Behavioral Neurology and the Center for Functional Neuroimaging at the
University of Pennsylvania join forces to offer a post-doctoral research training program in Translational
Neurorehabilitation Research, built on the platform of more than 15 years of multidisciplinary
collaboration. The program will train 5 postdoctoral fellows at a time, recruited from basic science and
clinical disciplines, using a mixture of didactic and hands-on training methods. Added this cycle are
positions for 2 short-term summer training positions annually for medical students from underrepresented
minorities. Program faculty collectively have expertise in 5 key themes that are critical to maturation of
treatments from initial concept to validated treatment, including: Theories of normal and abnormal
processing; Impairment assessment; Naturalistic assessment; Modulation of neuronal plasticity and
learning mechanisms; and Theory-driven treatment trials, and are experienced in a range of cutting edge
research tools, including structural and functional neuroimaging, eye- and motion-tracking, computational
modeling, virtual reality, psychopharmacology, transcranial magnetic stimulation and transcranial direct
current stimulation. Moreover, several individual faculty and collaborative groups have demonstrated
expertise in advancing assessments and treatments toward clinical implementation. Thus, trainees have
the ability to learn specific tools and perspectives that are applicable to neurorehabilitation research, while
benefiting from mentored exposure to the process of translating scientific advances into clinically useful
assessments and treatments.

Public health relevance
Central nervous system injuries and diseases frequently lead to persistent cognitive and movement impairments that limit independence, functional abilities, and quality of life. Advances in a number of scientific domains offer new tools to improve patient assessment and rehabilitation interventions. The proposed training program, led by a group of long-standing collaborators at Moss Rehabilitation Research Institute and the University of Pennsylvania's Department of Neurology, will prepare trainees to conduct translational neurorehabilitation research that will help turn these scientific advances into feasible assessment and treatment tools that can reduce the disabling effects of neurologic disease.